Neuron-satellite glia interactions in the sympathetic nervous system

The sympathetic nervous system is a key regulator of whole body physiology. A
dysfunctional sympathetic nervous system is linked to a growing list of human disorders
including chronic heart failure, hypertension, and insulin resistance. Despite decades of
research on sympathetic neurons, satellite glia, the major glial cells in sympathetic ganglia,
have remained an enigmatic component of the system. Satellite glia tightly ensheathe
sympathetic neuron cell bodies. In recent work, we revealed a role for satellite glial cells
in restricting neuron activity to thereby modulate sympathetic output to peripheral organs.
Our findings suggest that sympathetic neurons and their surrounding satellite glia should
be considered as structural and functional units that orchestrate the formation and
functioning of the sympathetic nervous system. However, satellite glia are a vastly under-
studied cell type in the nervous system, with limited understanding of their development,
neuron-glia communication, and how they contribute to neural circuits.
This application addresses this knowledge gap by seeking to define how
sympathetic neuron-satellite glia units are established during development, and how
perturbations in this process impact neuronal connectivity and function. Based on our
preliminary results, we hypothesize that target-derived neurotrophin signaling in
sympathetic neurons instructs contact-based interactions with neighboring satellite glia
during development. The goal of this application is to test this hypothesis and define the
molecular underpinnings of this bi-directional neuron-satellite glia interactions using
genetic mouse models, neuron-glia co-cultures, biochemistry, and imaging. Our studies
will establish a fundamental knowledge of how these poorly studied glial cells contribute
to nervous system connectivity and function and will inform new strategies for treating
disorders linked to sympathetic dysfunction.

Public health relevance
The sympathetic nervous system is a key regulator of whole body physiology. We recently showed that satellite glial cells, an often ignored cell type in the nervous system, are a key regulator of sympathetic neuron function. In this proposal, we will address how sympathetic neurons and satellite glial cells communicate with one another to influence the co-development of these two cell types. A better understanding of neuron-satellite glia interactions is critical for a fundamental knowledge of the normal sympathetic nervous system, and will guide new treatments for devastating disorders linked to sympathetic dysfunction such as chronic heart failure and hypertension.